Mentoring in mHealth and Social Networking Interventions for CVD Risk Reduction

Abstract. This K24 renewal will enable the investigator to continue a very successful transdisciplinary
mentorship program for digital health research focused on obesity and cardiovascular disease (CVD)
prevention. The candidate currently has 14 mentees ranging from high school to junior faculty level. In the four
years her K24 has been funded her mentees earned 104 co-authorships on papers and submitted 40 grants
(31 thus far) under her mentorship. The proposed mentorship plan will build additional training experiences into
her mentorship program by providing mentees with a transdisciplinary mentoring experience that represents
experts in behavioral science, preventive cardiology, health informatics, data science, and innovative research
designs. Mentees from collaborating labs at UMass Medical School, Penn State University, and Worcester
Polytechnic Institute will “embed” in each other's lab to learn a broad range of digital health research skills with
an emphasis on data science, innovative methodologies, and designing innovations with commercial potential.
Mentees will learn how to: utilize mobile apps and online social networks in their research; analyze social
network data; conduct qualitative and quantitative data analyses; leverage innovative research designs (e.g.,
MOST); employ behavior change strategies in mobile and social network environments; design preliminary
studies; and write grants. The candidate's training goals are to expand her research into implementation,
dissemination, and larger scale program projects; enhance her mentorship of young investigators seeking to
study innovative technologies; increase capacity to translate NIH-funded digital health innovations into the
healthcare economy; and increase capacity of the UConn Center for mHealth and Social Media to build a
national reputation for training in behavioral digital health research in CVD risk reduction. The overarching goal
of the research plan is to test ways to leverage social media to deliver health behavior programming in ways
that maximize efficacy, scalability, and dissemination potential. Three research aims are proposed, all of which
test the efficacy of cardiovascular disease prevention and/or weight management programs delivered via social
media. The first aim proposes to test the efficacy of a Facebook-delivered CVD prevention healthy lifestyle
program for young women. The second aim is to test the efficacy of a similar CVD prevention program but
tailored to adult family members in families that have already been impacted by a life-threatening disease. This
Facebook-delivered CVD prevention program will leverage family ties to promote behavior change. The third
aim is to conduct a feasibility trial of multiphase optimization strategy (MOST) study which will test the optimal
formats for goal setting and problem solving messages in a social media delivered weight loss intervention.
This work will provide preliminary data for 3 R01 applications. The proposed work will produce training
experiences and data that will contribute to the mentorship of the next generation of researchers who will have
transdisciplinary expertise to leverage social media in the delivery of CVD prevention interventions.

Public health relevance
This mid-career development award is designed to support mentoring in digital health research for cardiovascular disease prevention that leverages the resources of the UConn Center for mHealth and a transdisciplinary co-mentoring team. The Candidate's training model will equip mentees with: research methodology skills, knowledge of the “idea to market” process, opportunities to collect preliminary data, grant/manuscript writing experience, professional development, training in the ethical conduct of research, and “hands on” team science experience.